DYNAMIC NUCLEAR POLARIZATION: POLARIZATION TRANSFER IN FROZEN AQUEOUS SOLUTION

Dynamic nuclear polarization (DNP) transfers the large polarization of unpaired electrons to nuclei and thus significantly enhances the signal strength in nuclear magnetic resonance (NMR) spectroscopy. High frequency/field (140 GHz/5 Tesla) DNP has been implemented in solid state NMR experiments using a nitroxide radical as the paramagnetic polarizing agent in a water:glycerol frozen solution. The 1H and 13C NMR signal strengths of both the solvent and an amino acid solute have been enhanced by a factor of 185, which represents a reduction of >102 in sample size requirements or >104 in signal acquisition time.